Use of Clinical Samples to Identify Influenza Virus Antigenic Variants

Use of Clinical Samples to Identify Influenza Virus Antigenic Variants
Summary
Influenza A viruses (IAVs) cause pandemic and seasonal outbreaks that lead to the loss of thousands to
millions of human lives. Vaccination is the best option for preventing influenza outbreaks and minimizing their
effects. An understanding of the antigenic evolution of influenza viruses and the rapid selection of a well-
matched influenza vaccine strain is the key to developing an effective vaccination program. However, antigenic
characterization for influenza viruses presents two great challenges: 1) virus propagation, which is required in
conventional serologic assays, can cause culture-adapted mutations and skew antigenic properties of viruses
in clinical samples, and 2) reference sera used in conventional serologic assays are produced in influenza
virus–seronegative ferrets and do not represent the immunologic profiles of human serum, which often has had
prior exposures to influenza viruses through vaccination, natural infection, or both. An ideal platform for
determining antigenic properties of influenza viruses and for selecting influenza vaccine strain should directly
use clinical samples.
The objectives of this project are 1) to develop and apply a novel high-throughput technology to directly
characterize antigenic properties of influenza viruses by using human clinical samples without virus isolation
and propagation and 2) to understand antigenic evolution of IAVs by using clinical samples directly. The
antigenic characterization will include influenza virus–positive clinical samples from which virus can or cannot
be cultivated. To understand influenza virus quasispecies in clinical samples and the effect of culture-adapted
mutations on antigenic characterization, we will perform next-generation genomic sequencing on the clinical
samples and corresponding isolates. We will then study the effects of the sequence diversity on antigenic
variations of influenza viruses. We will also determine the effect that prior exposure to influenza virus(es) has
on antigenic characterization during influenza vaccine strain selection.
This project will help us provide fundamental technology for characterizing the antigenicity of influenza
viruses in clinical samples without propagating virus. The resulting platform for antigenic characterization will
overcome biases arising from virus propagation in conventional serologic assays. In addition, this is a high-
throughput method and will significantly reduce the human labor needed for serologic characterization,
decrease the time required for antigenic characterization, and increase the number of samples in antigenic
characterization. Thus, this project will lead to significant technologic advances in influenza vaccine strain
selection and facilitate influenza prevention and control. In addition, this project will provide knowledge about
molecular mechanisms in antigenic variations associated with influenza virus quasispecies and genomic
diversity and knowledge about prior human exposure to influenza viruses, which will help us optimize antigenic
characterization in vaccine strain selection and understand antigenic evolution of influenza viruses.

Public health relevance
Narrative We propose to develop and validate a clinical sample–based strategy for influenza vaccine strain selection and to study molecular mechanisms for antigenic evolution of influenza viruses; study findings will lead to significant technologic advances in influenza prevention and control and contribute fundamental knowledge regarding influenza virus evolution.